Off-The-Shelf Dual Targeted NK Cells For NHL

Limiting relapse is the biggest challenge following autologous transplantation for non-Hodgkin’s lymphoma.
Antigen-directed CAR T cell products and other targeted therapies may be changing the field, yet for high-risk
lymphomas, new and safer approaches are needed. We will study the safety and efficacy of antigen-directed,
off-the-shelf, induced pluripotent stem cell (iPSC)-derived NK cells engineered for dual-antigen targeting. We
have optimized the differentiation of iPSC-derived CD34+ cells to highly potent NK cells, scaled production at the
University of Minnesota, and can now produce hundreds of doses in a manufacturing run with a clonal iPSC
transduced with a high-affinity, non-cleavable CD16 (called hnCD16). In late 2019, we initiated clinical trials
testing this engineered iPSC product (designated FT516). The overarching hypothesis for this project is that
dual targeting of NK cells with a CAR and through hnCD16 will protect against relapse after auto-transplant for
lymphoma and that future gene edits to alter metabolism will enhance adoptive transfer. This hypothesis fits with
the themes of this Program, and Project 2 will inform the Program on the development of off-the-shelf NK cells,
NK CAR, and the role of membrane IL-15, as well as pre-clinically on whether manipulating metabolism will
enhance NK cell therapy. These investigations are supported by the following Specific Aims. Aim 1 will test dual
targeting of NK cells to CD19 and CD20 using two mechanisms of action, ADCC and an NK CAR, to prevent
relapse after autologous transplantation for lymphoma. We will test a triple gene-modified iPSC-derived NK cell
product (FT596) transduced with hnCD16, an NK cell-optimized CD19 CAR, and membrane bound 15/IL-15Ra
fusions. FT596 will be combined with rituximab as maintenance therapy to limit relapse after autologous HCT.
This trial is FDA-approved and will first establish an MTD at day +30 after engraftment and then, if single dosing
is safe, move to day +7 before engraftment with the goal of 3 doses in the first hundred days to prevent relapse.
Aim 2 will test enhancement of NK cell metabolic fitness by ARID5B overexpression and CD38 knockout. Our
preliminary data shows both adaptive NK cells and CD38 knockout iPSC-derived NK cells resist oxidative stress-
induced cell death. ARID5B overexpression, naturally increased in adaptive NK cells, mediates similar effects.
We will generate new iPSC lines to build on FT596 with transgenic expression of ARID5B or a CRISPR knockout
of CD38. These clones will be evaluated to probe the mechanisms on how they drive NK cell metabolism and
augment function. Aim 3 will test whether manipulating ARID5B and CD38 will drive metabolic fitness and
enhance FT596 persistence and function in vivo. These pre-clinical trials will inform future clinical trial
modifications—all to promote enhanced anti-lymphoma activity by extending transferred NK cell persistence and
potency. These metabolic and potency findings will directly inform Project 1 to improve cell targeting and
metabolism, Project 3 for cell persistence, and all 3 Projects to define the advantages of autonomous
presentation of IL-15.

Public health relevance
Malignant relapse is the biggest reason for failure in treatment of lymphoma. Natural killer (NK) cells can target lymphoma, and we will study genetically engineered, off-the-shelf NK cells directed to multiple targets on lymphoma as new “smart bomb” cellular treatments to limit relapse. Future improvements to enhance NK cell persistence and potency may make this therapy safer, cheaper, and even more effective.